Synergistic role of signaling and epigenetics in leukemic transformation

PROJECT ABSTRACT
We propose to use single cell studies of clinical isolates to explicate how mutations and differentiation status
coordinately regulate cell state, clonal expansion and malignant transformation. We will model sequential
activation/inactivation of somatic mutations in defined cell compartments and perform functional studies to
uncover critical gene networks and therapeutic dependencies. This will include single cell studies in primary
patient samples, use of innovative models which allow for sequential mutational activation/inactivation, and
functional genomic approaches to delineate mechanisms of transformation and novel therapeutic dependencies.
Moreover, we will delineate crosstalk between different cell types in normal and malignant hematopoiesis and
how these interactions impact therapeutic response. These tools will be distributed widely to enable studies of
tissue development/homeostasis, cell state changes, transformation, and therapeutic dependencies.

Public health relevance
PROJECT NARRATIVE We will use studies in patient samples and in innovative preclinical models to delineate how clonal evolution contributes to malignancy and to the response to cancer therapies. We will model clonal evolution using novel in vivo preclinical models and perform functional studies to delineate the key networks and targets which govern malignancy. This work will delineate how mutational evolution contributes to cancer initiation and progression and use these insights to identify novel therapeutic targets which can intercept/prevent or attenuate malignancy.